Communities of Practice for lay health worker-delivered contact investigation for TB: Mechanisms and context

Project Summary/Abstract
Tuberculosis (TB) remains among the top 10 causes of death worldwide, disproportionately impacting low-
income countries. Contact investigation for TB is recommended by the WHO to find and prevent additional
cases. Contact investigation is often carried out by lay health workers who receive on-the-job training;
however, lack of relevant in-service training is a major barrier to their delivery of high-quality health services.
One approach to facilitating lay health worker training is to implement Communities of Practice (CoPs). CoPs
are groups of professionals who meet regularly to support each other and share knowledge to advance their
practice toward a common goal. CoPs have been used in the health field to improve the delivery of high-quality
care by physicians and nurses in middle- and high-income countries. However, additional studies are needed
that identify how CoPs can be used to facilitate the performance of lay health workers in low-income countries.
My training proposal addresses the gaps in understanding how CoPs function in low-income countries
through two scientific aims and four training aims that leverage Dr. Luke Davis’ (Sponsor) implementation trial
of CoPs (5R01 AI104824-08, 2021-2023). Dr. Davis’ trial aims to address gaps in the implementation of TB
contact investigation in Uganda; our research team found that only 20% of high-risk contacts completed TB
evaluation in full, far below the WHO target of ≥90%. Separate from the funded trial, I will test my conceptual
model of how and in what contexts CoPs can improve delivery of contact investigation. In Aim 1, I will test my
hypothesis that lay health worker self-efficacy, or their confidence delivering high-quality health services,
mediates the effects of CoPs on contact investigation. I will seek training and mentorship in survey methods
and psychometrics to validate a widely used self-efficacy measure for use in Uganda. I will also receive training
and guided mentorship in mediation analysis to assess if lay health worker self-efficacy mediates the effects of
CoPs on contact investigation. In Aim 2, I will seek training and mentorship in advanced qualitative methods to
identify contextual factors that impact the effectiveness of CoPs. By evaluating mechanisms of action and
contextual factors pertinent to CoPs, our findings can explain why the parent trial improved, or failed to
improve, outcomes. Our findings will also yield insights on how to design and implement lay health worker
CoPs to improve delivery of high-quality health services, which can be applied to other low-income settings.
My training plan and the collaborative environments at Yale and the Uganda TB Implementation Research
Consortium will allow me to develop research, clinical, and professional skills needed for a research career as
a physician-epidemiologist who uses implementation science to mitigate health disparities in low-income
countries. My training plan outlines coursework, mentored research, and clinical experiences to enhance my
skills in implementation trials, advanced biostatistics, qualitative methods, and infectious diseases medicine.

Public health relevance
Project Narrative Lay health workers are commonly used to screen people for tuberculosis (TB) in high-burden settings; however, they often have minimal prior clinical experience, which impacts their ability to efficiently screen patients for TB. Organizing lay health workers into a formal group, or Community of Practice, that has regular meetings to discuss their challenges and brainstorm solutions could be an effective way to improve their performance. Through the specified aims, I will use a combination of quantitative and qualitative research methods to identify how Communities of Practice improve the delivery of TB care, and contextual factors that are important for their functioning.